PATHWAYS OF RECEPTOR SIGNALING AND CHEMOTAXIS

Chemotaxis is coordinated by both positively and negatively acting (adapting) intracellular pathways, and receptor phosphorylation in other systems is required to turn off downstream signaling. Dictyostelium uses the 7-TMR CAR1 to sense secreted cAMP to coordinate movement into aggregates in response to starvation. Essential to aggregate formation is the ability for most CAR1-mediated pathways to quickly adapt to a cAMP stimulus and for cells to rapidly destroy the cAMP ligand by secreted phosphodiesterases. CAR1 activates multiple networks, including the cAMP-synthesizing-pathway adenylyl cyclase A (ACA), and also initiates its own phosphorylation. We now demonstrate that receptor phosphorylation is required for adaptation of the ACA pathway: ACA does not adapt in cells expressing non-phosphorylatable CAR1 mutants in the presence of persistent signal. Consistent with these results, we find that propagation of the cAMP signal is significantly compromised when mutant cells are allowed to aggregate on a solid substrate, but evidence of cAMP oscillations during aggregation is still observed, suggesting that the inability to suppress cAMP synthesis is partially compensated in situ.[unreadable] AKT and PKBR1 are two related protein kinases that play pivotal roles in Dictyostelium chemotaxis. PKBR1 is anchored constitutively at the plasma membrane via a myristoylation tag, whereas AKT possesses a PH-domain and is transiently recruited to the membrane upon the PI3K-dependent accumulation of the lipid moiety PIP3. We have found that PKBR1 and AKT are phosphorylated upon stimulation by both the growth-specific chemoattractant folate and the developmental-specific chemoattractant cAMP. We systematically investigated components involved in cAMP regulation of AKT/PKBR1 and show a connection of CAR1 to Ga2bg; downstream, the GefA-RasC pathway is activated. The RasC effector PI3K is required for AKT function, but not for PKBR1, and in pten-null cells, only AKT activity is enhanced. 2 protein kinase activities are required to regulate AKT/ PKBR1. Phosphorylation within the activation loop is mediated by PDK1, while phosphorylation within the C-terminal HM region requires TORC2. HM phosphorylations on AKT and PKBR1 are dependent on Rictor/Pia, SIN1/RIP3, and LST8 and full TORC2 integrity, strongly suggesting TORC2 functions in chemotaxis and development through phosphorylation of AKT and PKBR1.